ComPASS Health Equity Research Hub at Yale

ABSTRACT
The Community Partnerships to Advance Science for Society (ComPASS) Health Equity Research Hub at Yale
(Yale ComPASS Hub) will support select community-led health equity structural interventions (CHESIs) as
identified by ComPASS leadership and will synchronize with the ComPASS Coordinating Center and the
broader ComPASS program to provide thematic technical assistance across food/nutrition security,
intergenerational family interventions, poverty-reduction, cultural resilience, and participatory research and
implementation approaches. These thematic areas represent the extensive expertise of the team and address
challenges encountered in diverse settings throughout the U.S. The Yale ComPASS Hub has the capacity to
expand the breath of technical assistance thematic areas as CHESI needs are identified. The Yale ComPASS
Hub will use community-academic partnerships to tailor and deliver responsive, accessible, and
transformational technical assistance to CHESIs as they generate new scientific knowledge about community-
led structural interventions to advance health equity. The overall aim of the Yale ComPASS Hub is to provide
evidence-derived technical assistance and capacity-building support to CHESIs based on collaborative
processes and practical guidance adapted by partnered academic and community leader Hub unit teams. Hub
units will each be co-led by Academic and Community Director teams with almost two decades of experience
working collaboratively on health equity-related research or practice initiatives. The Yale ComPASS Hub will
elevate the role of partnered research and decision-making in grant governance and implementation, bring
diverse methodological and analytical research expertise to facilitate transdisciplinary collaboration,
meaningfully engage community members to more equitably partner in co-creation and implementation of
research, and elevate the science of community engaged research to drive health equity.

Public health relevance
PROJECT NARRATIVE The ComPASS Health Equity Research Hub at Yale is a multidisciplinary collaborative of community-engaged researchers that demonstrates the value of integrating diverse perspectives into health equity solutions. Using partnered academic-community teams, the Hub assesses assets and needs, and then tailors and evaluates training and capacity building in research methods, data management, community engagement, and health equity for community-led health equity structural interventions (CHESIs) focused on food/nutrition security, intergenerational family interventions, poverty-reduction, cultural resilience, and participatory research and implementation approaches. Our collaboration long-term goa l is to advance the science of community engagement in with other researchers committed to sustainable health equity.